Protein purification instrumentation in support of single molecule studies of genome integrity

My group has a long?standing interest in understanding the molecular mechanisms that contribute to cancer biology and genome integrity. To provide new insights into the mechanisms of genome integrity we have pioneered the development of DNA curtains, which allow for the direct visualization of hundreds to thousands of individual molecules in real?time by optical microscopy. This experimental platform is applicable to many types of protein?nucleic acid interactions and allows us to address questions about complex biological problems that cannot be addressed through traditional approaches. Our success in with this technology has uniquely positioned the lab to reveal new concepts regarding the mechanisms of genome integrity. Our use of this novel single molecule methodology is dependent upon access to highly purified recombinant proteins. This Supplemental Equipment request will allow us to replace our outdated protein purification system so that we can continue moving forward on our research efforts into understanding the mechanisms of genome integrity.

Public health relevance
PROJECT NARRATIVE Double-stranded DNA breaks (DSBs) can cause gross chromosomal rearrangements, which are the hallmark of all forms of cancer. The overall goal of our research is to study the events that lead to DSB formation and the mechanisms that cells use for DSB repair, in the hope that this research will eventually lead to a better understanding of how might be able to prevent or cure cancer.